Administration

This core will: promote high quality collaborative research by providing a supportive academic environment in which investigators can carry out scientific projects, facilitate the interaction of projects and cores, oversee the administration and financial aspects of the Program Project, interact with core facilities effectively, foster new research projects and enhance scientific productivity.